Pharmacokinetics of Anti-tuberculosis and Antiretroviral Drugs in Children

Tuberculosis (TB) and human immunodeficiency virus (HIV) infections are major causes of morbidity and
mortality in children. Children are highly susceptible to the dual epidemics of HIV and TB infections especially
in Africa. HIV-infected children are at a higher risk of developing active TB and dying of TB. The high risk of
death in children with TB/HIV coinfection is in part due to delayed therapy or suboptimal drug treatment of one
or both infections. In particular, suboptimal pharmacokinetics (PK) due to inappropriate drug formulations or
dosing may contribute to the high mortality in children. The lack of PK data of new pediatric formulations rolled
out for the treatment of TB and HIV in children in Africa represents a major obstacle to optimized outcomes.
Our long-term goal is to generate novel PK data of the new fixed-dose combination (FDC) formulations of anti-
TB and antiretroviral drugs used in children and adolescents in Africa. Our primary objective is to determine the
PK and covariates associated with interindividual variability in the PK of the new child-friendly FDC formulation
of isoniazid/rifampin/pyrazinamide for children as well as generic FDC antiretrovirals used in adolescents. The
overarching hypothesis is that previous studies have underestimated the effect of developmental and genetic
factors in drug metabolism, drug-drug interactions, as well as the risk for suboptimal drug concentrations in
children. Our goal will be pursued through three specific aims. Aim 1 will evaluate the PK of the new pediatric
isoniazid/rifampin/pyrazinamide FDC formulation, and use the PK data to develop a population PK model and
stimulations to predict optimal weight-band dosages for children. Aim 2 will examine the effect of rifampin-
containing anti-TB therapy on virological response in children with TB/HIV coinfection compared to those with
HIV alone treated with efavirenz-based therapy. Aim 3 will determine the intracellular PK of tenofovir
diphosphate and emtricibaine triphosphate in adolescents aged 10 to 19 years old, as well as examine the
effect of age and TB coinfection on the PK of these anabolities. As new pediatric formulations of anti-TB and
ARVs are scaled up in sub-Saharan Africa, PK and PK-PD data in African children are needed to either
validate the formulations and dosing guidelines or provide relevant data for guidelines revisions. This
innovative proposal has the potential to provide critical data for optimization of treatment regimens for
childhood TB, HIV and TB/HIV coinfection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Globally, ~one million new cases of tuberculosis (TB) and ~210,000 TB deaths occurred in children in 2015. In the same year an estimated 1.8 million children were living with human immunodeficiency virus (HIV), 150,000 became newly infected and 110,000 died of AIDS-related illness. Sub- Saharan Africa is disproportionately affected by these infections but optimized treatment of these conditions is limited by the lack of pharmacokinetic and pharmacokinetic-treatment response data of the drugs used in the region. Our research will provide critical pharmacokinetic data of new pediatric formulations and generic fixed- dose combination tablets prescribed to children adolescents that could be used to optimize treatment of TB, HIV and TB/HIV coinfection in Africa.